Basic and Clinical Research Training for Medical Students

PROJECT SUMMARY
Continued funding is requested to support the NHLBI-T35 training program at Loyola University Chicago
Stritch School of Medicine. Our program introduces early stage medical students to the challenges and
excitement of research by providing a mentored summer research experience with the ultimate goal of
inspiring trainees toward academic careers that incorporate basic biomedical and clinical research. The
program exists as a dedicated, NHLBI-focused research and career development program that leverages the
successful administrative framework of our Student Training In Approaches to Research (STAR) Program. The
T35 program provides students between their first and second year of medical school with a focused eight-
week mentored training experience pursuing NHLBI-related research resulting in completion of a research
project and formal presentation of their work. The Stritch School of Medicine is a rich academic environment
and a leading institution in cardiovascular and hematology-related research and clinical care. We have a team
of twenty-five experienced mentors whose research covers epidemiology; genetics; molecular, cellular and
pathophysiological mechanisms of disease; translational research; and patient-oriented clinical research. The
student’s full-time research training is supplemented with didactic conferences on topics including experimental
design, data management, responsible conduct of research, professional development, and presentation skills.
Trainees are chosen through a competitive process based on their proposed research plan and goals for the
summer experience. The T35 program includes student assessments to evaluate the quality of the research
experience and didactic offerings as well as our short and long-term success at encouraging students to
pursue academic careers that include research.

Public health relevance
PROJECT NARRATIVE Our T35 training program provides mentored summer research opportunities for early stage medical students with the goal of inspiring a passion for biomedical research. Through hands-on research training supplemented with didactic conferences on research and career development topics, we will introduce students to the excitement and challenges of research and encourage them to pursue careers the integrate research with clinical care.